Elucidating the Mechanism in the Regulation of RNA-binding Protein Phase Separation

Abstract:
Liquid–liquid phase separation of RNA-binding proteins (RBP) is a recently appreciated means of intracellular
compartmentalization underpins the biogenesis of diverse membraneless organelles. Despite clear biological
utility, dysregulated phase separation of RNA-binding protein (RBP) leads to protein aggregation and fibrils
formation, which are key pathological features of numerous neurodegenerative diseases. The central hypothesis
of my work, and the driving force of my lab, is that reversing aberrant phase transition and aggregation is a
potential avenue to combat these fatal diseases. In fact, we and others have established that nuclear import
receptors (NIRs) such as Kapβ2 can reverse protein aberrant phase transition and elevated Kapβ2 expression
can suppress neurodegeneration caused by disease-linked RNA-binding proteins. Thus, NIRs and other
regulators of protein phase transition could be leveraged therapeutically to restore normal function of
membraneless organelles and mitigate proteotoxicity caused by aberrant phase transition. However, several key
knowledge gaps regarding the regulation of phase transition must be filled, to lay the foundation to develop such
therapeutic strategies. Thus the long-term goal of my research program is to achieve a more comprehensive
understanding of the regulatory mechanism of protein phase separation and leverage our understanding of
phase regulation to develop strategies with therapeutic potential to reverse proteotoxicity induced by aberrant
phase transition. I seek to elucidate the molecular mechanism of the regulation of protein phase separation, both
in health and disease conditions.
We propose to focus on three main themes over the next five years: (1) Define the mechanism of how Kapβ2
reverses protein aberrant phase transition. (2) Define the scope and specificity of Kapβ2 and other nuclear import
receptors in their function in regulating phase separation in live cells. (3) Based on our preliminary results that
RNA oligonucleotides with specific sequences have diverse activities in regulating RNA-binding protein phase
separation, we will identify the sequence space of RNA in regulating RBP phase separation and develop
innovative single-molecule fluorescence-based biophysical methods to understand the mechanism of RNA’s
function. Our work will significantly contribute to our understanding of the regulatory mechanism of phase
separation in cells and how the breakdown of this regulation leads to disease conditions. Furthermore, this work
will set the stage for developing strategies to enhance the activity of Kapβ2, as well as RNA-based
oligonucleotides that can mitigate toxic aberrant phase transition, both of which provide the basis for developing
innovative therapeutics to restore the healthy protein phase in cells.

Public health relevance
Project Narrative Liquid–liquid phase separation of proteins and nucleic acids drives the biogenesis of diverse membraneless organelles with important biological functions. Dysregulated phase separation of RNA-binding proteins leads to the formation of toxic fibrils, which is a pathological hallmark in multiple fatal neurodegenerative diseases. Elucidating molecular mechanisms of phase separation regulation and developing strategies to reverse aberrant phase transition and fibrillization will lay the foundation for advances in novel therapeutic strategies to combat these fatal diseases.